Cancer Center Administration

PROJECT SUMMARY CANCER CENTER ADMINISTRATION
The overall mission of The Jackson Laboratory Cancer Center (JAXCC) is to bring genomic solutions to cancer
medicine. We continue to develop a culture of scientific discovery, excellence, transdisciplinary research, and
collaboration to yield tangible benefits to cancer patients extending beyond the generation of new knowledge.
This mission is supported by the Jackson Laboratory Cancer Center (JAXCC) Administration (Admin) Core. The
Admin Core plays a crucial role in overseeing and streamlining key processes to efficiently accomplish the
JAXCC's Strategic Objectives. It also serves as the central hub facilitating cross-disciplinary and cross-campus
collaborations. The Admin Core is directly responsible for management of the following: the strategic plan, CCSG
reporting and the renewal application, Cancer Center budgets and philanthropic funds, internal Developmental
Funds award, membership, and cancer relevance assessment processes, Governance and upholding standard
operating procedures, ensuring policy maintenance across the Center, Center management Committees, and
Center collaborative meetings and events, as well as their documentation. Admin supports the Shared
Resources Management team to monitor and assess usage. Additionally, Admin assists the Director in
preparation for Bar Harbor and Farmington Space Committee discussions and with aspects of faculty
recruitment, including overseeing JAXCC membership invitation letters. Admin is a dedicated management team
consisting of an Associate Director for Administration (AD Admin), who is a member of the JAXCC Senior
Leadership, and two Assistant Directors of Administration (AstD Admin), one at each of our research campuses
in Bar Harbor, ME and Farmington, CT. This facilitates effective liaising with Center members and institutional
offices. Admin integrates institutional and JAXCC administrative and operational processes to achieve the
following Specific Aims: Aim 1: Support the JAXCC Director in ensuring implementation and accountability for
the Strategic plan and Center governance; Aim 2: Support JAXCC Senior Leadership in building transdisciplinary
cancer research and team science; and Aim 3: Sustain and advance CCSG-related administrative activities.